Uncovering the mechanistic drivers of hepatic dysfunction in LIPT1 deficiency

PROJECT SUMMARY/ABSTRACT
Inborn errors of metabolism (IEMs) are genetic diseases that often cause severe illness and death in infancy or
early childhood. IEMs represent the largest subset of genetic diseases in children, numbering over 1000, with a
combined incidence greater than 1 in 1000. For some IEMs, early identification and intervention permit normal
development, but in many cases, an incomplete understanding of IEM pathophysiology limits therapeutic options.
Defects in lipoic acid (LA) metabolism represent a recently described category of IEM that causes complex
metabolic disease, liver injury, and neurodevelopmental delay. Little is known about the mechanistic drivers of
pathology in patients with these defects, and identification of key accumulated or deficient metabolites in vivo
holds promise to inform therapeutic intervention.
Lipoylation, or the addition of an LA moiety to a target protein, is required for the function of specific metabolic
enzymes referred to as 2-ketoacid dehydrogenases. These enzymes are critical contributors to central carbon
metabolism and include pyruvate dehydrogenase (PDH) and α-ketoglutarate dehydrogenase (α-KGDH).
Lipoyltransferase-1 (LIPT1) catalyzes the transfer of an LA moiety to the 2-ketoacid dehydrogenases. LIPT1
deficiency in patients results in severe illness with restricted growth and neurodevelopmental delay. In healthy
individuals, metabolic flexibility in the liver permits mobilization of energy stores during growth and development
to maintain homeostasis. Hospitalizations and deaths in patients with IEMs often occur during periods of
homeostatic decompensation. I hypothesize that impaired central carbon metabolism in LIPT1 deficiency
restricts hepatic metabolic flexibility, destabilizing maintenance of homeostasis.
Preliminary data reveal that knockout of Lipt1 in mouse livers results in acute weight loss and death 6-8 weeks
after induction, while mice with developmental loss of Lipt1 in the livers display restricted growth with ~40%
lethality by 20 weeks of age. With these novel, complementary models, this proposal will dissect the impact of
developmental loss of lipoylation from the role of lipoylation in healthy liver physiology. If successful, it will define
the metabolic alterations driven by lipoylation loss and attenuate these alterations with targeted dietary
intervention to bypass blockades at both PDH and α-KGDH.

Public health relevance
PROJECT NARRATIVE Defects in lipoylation represent a recently identified class of inborn error of metabolism that causes severe illness, restricted growth, and death in children. Patients with these diseases present clinically with liver injury, and induction of liver specific lipoylation deficiency in mice precipitates acute weight loss and death 6-8 weeks after induction. This project will define the role of lipoylation in liver metabolism, investigate the drivers of hepatic disease in lipoylation deficiency, and trial targeted dietary supplementation to attenuate metabolic dysfunction.